Neural Basis of Math and Aphasia

Project Summary
Despite the importance of math skills in daily life tasks, relatively little is known about the neural correlates of
math or its interaction with language processing in the brain. Prevailing literature posits that number sense, the
ability to grasp the concept of numbers, can be understood as two forms of numeracy: precise and approximate.
Unlike approximate numeracy, which is considered to be the innate ability to understand magnitude, precise
numeracy is thought to be strongly tied to language as it relies on symbolic communication and higher cognitive
skills. However, the neural basis of precise numeracy is significantly less studied than approximate numeracy,
and its connection to language areas has not yet been explored. This novel work investigating the neural
correlates of numeracy through the lens of known language areas and pathways will shed light on math abilities,
particularly as they relate to language, and will improve understanding of the consequences of related disorders,
such as the frequently co-morbid aphasia and acalculia following stroke. In order to fill in these knowledge gaps,
the project uses the lesion method to perform targeted region-of-interest (ROI), voxel-based, and tract-based
lesion-symptom analyses involving structural magnetic resonance imaging (T1, T2, FLAIR MRI) and diffusion-weighted imaging (DWI). Data will be drawn from a sample of 75-125 individuals with left-hemisphere focal
lesions due to stroke. The project draws from an extensive array of numeracy and language behavioral data,
coupled with multimodal neuroimaging data that allows for different types of lesion-symptom analyses. The
hypothesis states that precise numeracy is supported by both the intraparietal sulcus (IPS) area that has
been strongly linked to approximate numeracy, and brain regions associated with language ability. This
leads to a further hypothesis that deficits in precise numeracy associated with damage to language-related regions and pathways will co-vary with deficits in language functions. In order to investigate the
relationship between language and numeracy processes, Aim 1 will use a targeted ROI approach to investigate
ROIs implicated in numeracy and language literature. Aim 2 will perform a data-driven factor analysis across a
set of 11 numerical and language neuropsychological measures, and then use the results in a multivariate lesion-
symptom mapping analysis to elucidate brain regions that contribute to both language and numeracy skills. Aim
3 will explore white matter connectivity of the numeracy and language networks through the use of univariate
and multivariate lesion-symptom analyses based on diffusion-weighted brain volumes. This research will
culminate in knowledge of both gray matter structures and white matter connectivity of the numeracy network,
particularly as it relates to the language network. Through a broad range of neuroimaging techniques and
quantitative methodology that address a novel area of symbolic communication research, the proposal will be
invaluable to numeracy and language research and the applicant’s ultimate goal of employing an interdisciplinary
approach for her career as an independent investigator studying language, numeracy, and cognition.

Public health relevance
Project Narrative Despite the importance of math skills in daily life tasks and the role of mathematics as a symbolic communication system, relatively little is known about the neural correlates of math or its interaction with language processing in the brain. The proposed research will explore this relationship by utilizing the lesion method and converging with a functional dataset, which will inform cognitive models of how numeracy abilities are organized in the brain and linked to language areas during both functional and disordered performance. This novel work investigating the neural correlates of numeracy through the lens of known language areas and pathways will shed light on math abilities, particularly as they relate to language, and will improve understanding of the consequences of related disorders, such as the frequently co-morbid aphasia and acalculia following stroke.